Administrative Core/Leadership

UCSF Fresno will coordinate and execute the recruitment, enrollment and data/sample collection for all prospective study cohorts associated with Projects 2 and 3. Details of the data and sample collection are described in the individual project protocols. Study cohorts of the piece-wise natural history (PWNH) design include four age groups, 0-2, 7-9, 15-19 and 19-22 year olds. With the exception of birth data, all study related visits will be conducted at the UCSF Fresno Center for Clinical and Translational Research. The 0-2 cohort will include 220 pregnant women, with maternal data collected during the second trimester (< 22 weeks) and infant data collected at birth, 12 and 24 months post-natal. Pregnant women will be recruited from multiple peri-natal clinics associated with the UCSF Fresno Obstetrics Department. All births associated with these clinics are performed at the UCSF Fresno-affiliated hospital. Community Regional Medical Center. We will also enroll 220 children for the 7-9 year old cohort, 50% of whom will have been previously diagnosed with asthma. During the CHAPS P20 grant period, 300 children (100 with asthma) were successfully enrolled in Project 2 through a partnership between UCSF Fresno (Mr. Tyner) and Fresno Unified School District. Similar recruitment methods will be applied for this new cohort. Data/samples will be collected at two time points: enrollment (visit 1) and 24 months post-enrollment (visit 2). In addition, 100 adolescents (15-19 years) previously enrolled in the above mentioned CHAPS P20 project and 100 young adults (19-22 years) previously enrolled in FACES will be re-contacted and enrolled for a single data/sample collection visit.

Public health relevance
This study will provide new information related to the potential health effects of air pollution in a region with some of the worst air pollution, highest asthma and obesity rates and poorest, most underserved populations in the country. Further, this study will help identify the possible mechanisms, timings and population-specific vulnerabilities underlying the health effects of air pollution.